Genomics

The Genomics Shared Resource (GSR) is a state-of-the-art genomics facility dedicated to providing the latest genomic research tools at low cost. The primary goal of GSR is to facilitate high-impact cancer research by Stanford Cancer Institute (SCI) members by providing genetic and genomic-based tools. This goal is accomplished by providing SCI members with unencumbered, comprehensive and cost-effective access to cutting-edge genomics technologies and all the necessary services, expertise and scientific support necessary to utilize these technologies to further cancer research. Major GSR technologies and services include: high-throughput sequencing, microarray-based analysis, real-time quantitative PCR, and multiplex single-molecule analysis. Expert guidance with the use of each technology is also provided throughout the entire experimental process, including guidance with experimental design, data analysis, data archiving and publication. The resources of the Stanford Functional Genomics Facility (SFGF), Protein and Nucleic Acid Facility (PAN), the Genome Sequencing Service Center (GSSC) and Genetics Bioinformatics Service Center (GBSC) have combined under the leadership of John Coller, PhD, as Director of the GSR, to provide the full spectrum of services with a total combined operating budget of $4.3M. Michael Eckart, PhD (PAN) co-directs the GSR. Arend Sidow, PhD, is the faculty advisor. Since 2009 over 130 SCI members have used the shared resource, representing all program affiliations. Future plans include expanding cancer specific bioinformatics support with the addition of one full time bioinformatician, upgrading high-throughput sequencing instrumentation, and continuing to expand sample and library preparation services.